Salivary gland cancer stem cells

PROJECT SUMMARY/ABSTRACT
The Problem: Mucoepidermoid carcinoma (MEC) is the most common malignant salivary gland cancer. The
treatment for MEC still is radical surgery and radiotherapy (in selected cases), as no systemic therapy has been
approved for this cancer. Consequently, current treatment strategies are typically associated with high morbidity,
poor quality of life, frequent tumor relapse and low 5-year survival rates for patients with advanced disease.
Rationale: Relentless tumor growth, resistance to cytotoxic therapy and high incidence of tumor relapse are the
major challenges in MEC treatment. Our group demonstrated that MEC progression is mediated by a relatively
small population of tumor-initiating cells that exhibit a stem-like state characterized by multipotency and self-
renewal, named here cancer stem-like cells (CSC). In MEC, cancer stemness is exhibited by cells with high
aldehyde dehydrogenase (ALDH) activity and high CD44 expression (ALDHhighCD44high cells). These cells are
uniquely resistant to cytotoxic therapy. Surprisingly, cytotoxic agents not only do not kill CSCs, but actually induce
cancer stemness while inhibiting tumor growth. In our search for a targetable vulnerability of MEC CSCs, we
made the following observations: A) The decrease in MEC CSC fraction mediated by therapeutic inhibition of
either mTOR or MDM2-p53 signaling is associated with downregulation of Bmi-1 expression. B) Bmi-1 is
constitutively upregulated by MEC CSCs. These observations suggested that Bmi-1 may play a significant role
in MEC CSCs that could be exploited therapeutically. Bmi-1 is a component of the polycomb repressive complex-
1 (PRC1) that functions as a critical regulator of stem cell self-renewal. However, Bmi-1’s effect on MEC
tumorigenesis and cancer stemness are unknown. Notably, recent clinical trials in patients with ovarian cancer
and pediatric glioma are exploring the safety/efficacy of a novel class of small molecule inhibitors of Bmi-1.
However, it is unclear whether therapeutic inhibition of Bmi-1 is sufficient to overcome the intrinsic resistance of
MEC CSCs to cytotoxic agents. Here, we propose mechanistic and translational studies using a combination of
genetic and pharmacologic approaches to understand the function of Bmi-1 and the therapeutic potential of
targeting Bmi-1 in MEC. Our overall hypothesis is “Bmi-1 drives tumorigenesis and chemoresistance in MEC”.
To address this hypothesis, we propose the following specific aims: S.A.#1: To define the function of Bmi-1 on
MEC tumorigenesis. S.A.#2: To define the effect of therapeutic inhibition of Bmi-1 on MEC stemness and tumor
relapse. S.A.#3: To determine the effect of an anti-CSC strategy (Bmi-1 inhibition) combined with an anti-bulk
tumor cell strategy (cytotoxic therapy) in preclinical trials conducted in xenograft models of resistant MEC.
Significance: This work will begin to define the effect of direct targeting of CSCs with Bmi-1 inhibitors on the
treatment outcome for MEC. Our long-term goal is to develop a mechanism-based therapy that prevents tumor
relapse and that improves the survival and quality of life of patients with MEC. Successful outcomes of this study
might be pertinent to the treatment of patients with other types of chemoresistant glandular malignancies.

Public health relevance
PROJECT NARRATIVE The studies proposed here will define the anti-tumor effect of a new treatment strategy based on targeted elimination of highly tumorigenic cancer stem-like cells combined with tumor debulking with conventional therapy in preclinical models of resistant salivary gland mucoepidermoid carcinoma. The overall significance of the proposed research lies in its potential to lead to discoveries that will ultimately improve the survival and quality of life of patients with salivary gland cancer. This is critical since current benefits of therapy are modest for these patients, and their survival rate remains unacceptably low.